Role of Calpain-7 in the Abscission Checkpoint

Project Summary:
As mammalian cells prepare to divide, the abscission checkpoint checks for residual mitotic errors and delays
abscission until the checkpoint is satisfied. Cells then complete cytokinesis and the two daughter cells are
irreversibly separated. Recent work has shown that loss of the abscission checkpoint leads to accumulation of
DNA damage and correlates with a predisposition to several different types of human cancer, indicating the
checkpoint plays an important protective role. Although we lack a complete understanding of checkpoint
signaling, it is already clear that the Endosomal Sorting Complexes Required for Transport (ESCRTs) are a key
regulatory target of the checkpoint. During cytokinesis, ESCRT complexes are recruited to and function in the
midbody between the dividing cells, where they constrict the membrane and mediate daughter cell separation.
However, these ESCRT activities must be negatively regulated to prevent abscission until the checkpoint is
satisfied. We have recently identified the protease Calpain-7 as a novel and essential checkpoint component. In
preliminary studies, we have characterized how the Calpain-7 MIT domain binds the ESCRT-III protein IST1,
determined the structure of the relevant Calpain-7 MIT-IST1 complex, identified point mutations that inhibit this
interaction, shown that IST1 recruits Calpain-7 to the midbody, and demonstrated that Calpain-7 catalytic activity
and ESCRT-III binding are required to maintain the abscission checkpoint. We now propose to gain a
mechanistic understanding of how Calpain-7 maintains the checkpoint by identifying substrates of Calpain-7
proteolysis and characterizing their functions (Aim 1) and by performing biochemical and structural analyses of
Calpain-7 regulation (Aim 2). Experiments in Aim 1 will utilize an unbiased, proximity-based TurboID/mass
spectrometry approach to identify candidate Calpain-7 substrates. These candidates will then be validated by
testing for Calpain-7 processing in vitro and characterizing their roles in abscission checkpoint maintenance in
cultured cells. Experiments in Aim 2 will provide structural and biochemical insights into Calpain-7 regulation,
including the mechanism of autoinhibition and the role of protein oligomerization in IST1 binding and midbody
recruitment. Together, these studies will provide important new mechanistic insights into the regulatory networks
and midbody assemblies that arrest cell division in response to mitotic errors.

Public health relevance
Project Narrative: Mammalian cell division is a highly regulated process, in part because proper genome maintenance requires that any errors arising earlier in the cell cycle be corrected before the dividing cells separate irreversibly. Our proposed studies will help to uncover the molecular mechanisms by which cells delay division until errors can be corrected, thereby providing insights into the fundamental process of cytokinesis and how its regulation prevents aberrant cell proliferation.